Role of RMTg afferents in mechanisms of withdrawal from chronic ethanol exposure

PROJECT SUMMARY
A significant number of individuals struggle to maintain sobriety as a result of withdrawal symptoms that emerge
during early abstinence from alcohol. Despite this, pharmacotherapeutics for the treatment of withdrawal are
lacking, at least in part, due to poor understanding of the mechanisms underlying symptoms of withdrawal. The
rostromedial tegmental nucleus (RMTg) is a GABAergic region that exerts inhibitory control over midbrain
bioaminergic and cholinergic nuclei. Recently, work from our lab revealed significantly enhanced cFos
expression, a marker of recent neuronal activity, in the RMTg of chronic intermittent ethanol (CIE) exposed rats
12 hours into acute withdrawal. In addition, we showed that pharmacological inhibition of the RMTg attenuates
withdrawal-induced anxiety-like behavior. However, the precise neural circuits that drive this putative RMTg
hyperactivity is unknown. The lateral habenula (LHb) provides dense glutamatergic input to the RMTg and
exhibits significant functional overlap with the RMTg. In addition, our preliminary data reveals a significant
increase in cFos expression in RMTg-projecting lateral habenula (LHb) neurons during acute withdrawal.
Together, these data lead us to hypothesize that LHb inputs to the RMTg play a mechanistic role in regulating
symptoms of withdrawal from chronic ethanol exposure. Experiments in the current proposal are designed to
test this hypothesis by using in vivo chemogenetics to bidirectionally and selectively manipulate LHb-RMTg
activity during behavioral tests of withdrawal symptoms including anxiety-like behavior, mechanical pain
sensitivity, and impulsive choice. Additional work will use ex vivo slice electrophysiology to explore the
physiological neuroadaptations that occur in this circuitry during withdrawal from chronic ethanol exposure.
Findings from these experiments will shed new light onto the role of this neural circuit in regulating symptoms of
withdrawal and by extension have the potential to uncover new neurobiological targets for the treatment of
alcohol use disorder.

Public health relevance
PROJECT NARRATIVE The neurobiological mechanisms underlying symptoms of withdrawal are poorly understood despite the fact that they serve as potent triggers for relapse in individuals attempting to remain abstinent from alcohol. While our recent work uncovered a role for the rostromedial tegmental nucleus (RMTg) in regulating withdrawal symptoms, the broader neural circuitry that governs this effect remains unknown. The proposed project will interrogate the mechanistic involvement of input from the lateral habenula to the RMTg in symptoms of withdrawal and in doing so provide an opportunity to identify new potential therapeutic targets for the development of drugs to treat withdrawal symptoms.